Core C Administrative Core

SUMMARY
The Administrative Core will provide operational support to the multi-institutional Program Project to enhance
research synergy, Program development and data and materials sharing in order to achieve the overall goal of
investigating structure-based mechanism and the discovery of potent small molecule and peptidomimetic
antagonists of HIV-1 Env function in cell entry. To accomplish this effort, the Administrative Core will have five
objectives: [1] organize retreats, teleconference progress meetings and other communications between the
Investigators, the internal Executive Committee, and an external Scientific Advisory Board; [2] provide funding
and other assistance to the Scientific Advisory Board to enable their participation in an annual Program retreat
to review research progress and to provide advice for Program advancement; [3] integrate mechanisms for
sharing research results, data and materials through a secure Program website that will post progress reports,
publications, materials inventories and other outcomes of the Program; [4] provide written and oral reports to
NIGMS, the Scientific Advisory Board and all Project and Core groups; and [5] ensure Program-wide financial
management of the Program Project research effort and provide financial reports to NIGMS.